Protein Chemistry

PROJECT SUMMARY/ABSTRACT
Approximately 80% of drugs in the pharmacopeia are small molecules. Half of those small molecules act
on extracellular targets, and half act on intracellular targets. The remaining 20% of drugs are proteins, and
virtually all of those proteins are antibodies, hormones, or enzymes that act on extracellular targets. The
proposed research will enable proteins to act on intracellular targets. The proposed research program
takes advantage of new chemical reactivity that is applicable in a physiological context. The overall goal
is to develop a facile, general means to endow native proteins with the ability to enter the cytosol of
human cells with desirable consequences. The strategy is to esterify protein carboxyl groups by using
α-aryl-α-diazoamides. The basicity of these diazo compounds are tuned to enable the efficient
esterification of carboxyl groups in water. The resulting esterified proteins are analogous to small-
molecule prodrugs. Intracellular esterases make these modifications traceless, avoiding any compromise
to proper function or potential for immunogenicity. “Protein esterification” has an uncharted landscape.
Accordingly, work will begin by exploring fundamental attributes of esterified proteins, including the
mechanism of cellular uptake and the enzymology of ester hydrolysis by cellular esterases. Esterification
will then be used to deliver proteins for eliciting cytotoxicity, tumor suppression, and genome editing.
The work relies on methods and ideas from chemical biology and allied fields, especially organic
chemistry and enzymology. The research will establish a new paradigm for developing chemotherapeutic
agents that are capable of addressing numerous unmet medical needs.

Public health relevance
RESEARCH STRATEGY Background. NIGMS grant R35 GM148220-02 supports research on protein chemistry. This grant is focused on an increasingly important challenge in biomedicine—the traceless delivery of proteins to the cytosol of human cells. This ability provides far-reaching, long-term opportunities for high-impact advances in biomedicine, chemical biology, and allied fields. This supplemental application is for a single piece of equipment that is critical for the completion of the proposed research. Need for the Requested Equipment. Grant R35 GM148220 proposes the use of diazo compounds to create “protein prodrugs”. In this approach, the esterification of protein carboxylates temporarily “cloaks” the anionic charge in a target protein (Figure 1), enabling membrane transversal. The internalized esters are hydrolyzed by cytosolic esterases, much like small- molecule prodrugs. This research requires the ability to monitor quantitatively (1) the synthesis of novel diazo Figure 1. Key aspects of the research supported by grant R35 GM148220 and structures of esterified proteins formed from novel cognate α-aryl diazo compounds. Resistance to spontaneous hydrolysis is conferred by either steric interactions or an intramolecular n→π* interaction that elicits the Pauli exclusion principle. Release is achieved by esterase- mediated p-quinone-methide formation. compounds, (2) the rate at which those diazo compounds esterify carboxylic acids, and (3) the kinetic stability of the ensuing esters in both the absence and presence of human esterases. In the first two years of support, we have learned that spontaneous hydrolysis can limit the practical utility of nascent esters. (A typical half-life is a few days.) Accordingly, we are now seeking diazo compounds that generate esters that are stable to spontaneous hydrolysis but removable by cellular esterases. Our strategy is to generate esters that are protected by steric effects or Pauli exclusion (as only one electron pair can occupy an orbital). The esters are designed to be cleaved by p-quinone methide formation. We have conceived of many new α-aryl diazo compounds along these lines (e.g., Figure 1). We now seek to make and test them. This request arises because there is an urgent, unexpected need for the requested equipment. First, our need for analytical chromatography greatly exceeds that expected upon submission of our grant application in January 2022 because of the need to make and test many new diazo compounds. Second, we have lost our ability to perform any analytical chromatography. Our laboratory had a functioning Agilent 1200 series HPLC instrument for analytical chromatography (Figure 2). This instrument was purchased in 2008 and was a workhorse for 16 years. With this instrument, we characterized hundreds of compounds and performed thousands of assays, leading to dozens of publications. Unfortunately, the instrument is broken and irreparable. We now have a daily need for this instrument that cannot be accommodated elsewhere. For example, the use of instrumentation facilities is slow and inefficient, does not allow for the use of columns appropriate for polar molecules like ours (e.g., C4 and HIC), and is expensive, putting an undue burden on the budget of our NIGMS grant. Description of the Requested Equipment. We request support for the purchase of an LC/MSD instrument from Agilent Technologies (Lexington, MA). This instrument uses powerful mass-selective detection to enhance analytical precision and is designed for efficiency. Its single quadrupole provides both flexibility and insight. The instrument has these capabilities that are essential for our research: Figure 2. Photograph of the rust-laden, nonfunctional 16-year-old analytical HPLC instrument in our laboratory. · High mass accuracy (±0.005 Da) · Flexibility to detect compounds with ESI, APPI, APCI, and multimode ion sources · Diode array detector with ultrafast scan speeds · Automated multisampler for vials and microplates · Simple, intuitive software that includes the OpenLab chromatography data system (CDS) · Rapid confirmation of interpretations through a library-match search technology This instrument would not only meet the urgent, unexpected need described above but also enhance the overall impact of grant R35 GM148220 by facilitating nearly all of the synthetic and analytical procedures inherent in the proposed research. Oversight and Training Plan. An engineer from Agilent Technologies would install the equipment, and a representative would provide training, both free of charge. To ensure that the requested instrument is accessible but maintained in like-new condition for the foreseeable future, we have designed a plan for instrument oversight. Specifically, we would house and maintain the instrument in MIT Room 18-344D, which is an equipment room within our laboratory. That location is ideal because of its central location and ready accessibility to personnel. A postdoctorate in our research group, Dr. Bjarne Silkenath, would facilitate the training of individual users and provide oversight. Dr. Silkenath is a synthetic organic chemist who has much experience in both liquid chromatography and mass spectrometry. He would host training events in which he would present the capabilities of the instrument to potential users. After attending such a session, individual users would contact him to request hands-on training, access to documentation on standard operating procedures, and certification to use the instrument independently. Certified users would be provided with the opportunity to sign up for a particular block of time on a first-come, first-served basis. Lastly, prior to leaving our research group, Dr. Silkenath would be responsible for appointing and training his successor, who would be chosen based on their experience with the instrument and their accountability. Other Users. The reach of the requested equipment supplement would extend beyond the laboratory of the PI. Specifically, the requested instrument would be shared with other departmental researchers, including Profs. Buchwald (R35 GM122483), Cummins (R01 GM130936), Movassaghi (R01 GM141963), Nolan (R01 GM118695 and R01 GM126376), and Shoulders (R35 GM136354). Notably, we have recently published joint papers with Profs. Buchwald, Cummins, and Movassaghi, and our groups have highly active collaborations. Cost of the Requested Equipment. We have negotiated a 28% discount on the list price for an LC/MS from Agilent Technologies. The price quote is attached to this application. To supplement this cost, we would provide a computer (~$2000) to operate the equipment, and we would use institutional funds to purchase a yearly service contract for ~$6000 per year (see below). Maintenance of the Requested Equipment. To ensure that the requested equipment is maintained in like-new condition, institutional funds would support a service contract from Agilent Technologies. The corporate headquarters of Agilent Technologies is in Lexington, MA, which is a 30-minute drive from our laboratory. Our department has many pieces of Agilent equipment and has negotiated a blanket contract to cover the cost of servicing that equipment. We project that the cost of servicing the new equipment would be ~$6,000 per year and would provide us with a yearly planned maintenance visit, technical assistance center service for operational and instrument set-up problems, and remote instrument diagnostics. Finally, we note that funds are not available in the budget of grant R35 GM044783 for the purchase of the requested equipment without the displacement of essential personnel. Summary We thank you for your consideration of this request for an equipment supplement, which is essential for the execution of the research proposed in grant R35 GM044783.